Virtual Reality Train the Trainer (VRT3)

Project Summary/Abstract
Charles River Analytics proposes to explore the feasibility of a Virtual Reality Train the Trainer (VRT3)
program that addresses the critical barriers to appropriately using VR training through a Phase I effort focused
on developing training and real-time support for instructors. VRT3 is significant because poorly implemented and
delivered VR training can have deleterious training effects when used in the wrong circumstances, or without
highly technologically literate trainers that are able to capture the full and appropriate value of these innovative
systems. The well documented and growing digital divide that would prevent broad adoption of VR training
systems presents a set of critical barriers that further drive inequities experienced by disadvantaged populations
who would otherwise benefit from these systems that are designed to keep people safe, healthy, and protect the
public health.

Public health relevance
Project Narrative VR training tools and technologies can make it more accessible, safe, and comprehensive for first responders and workers to get the training they need to effectively work in hazardous environments, where live training is limited, time-consuming, and unable to address the full extent of hazards. In order for the promise of VR to fully come to fruition, trainers and training organizations need to understand how best to insert and use virtual reality training in their existing offerings. We propose to explore the feasibility and develop a prototype VR “Train the Trainer” program (VRT3) that addresses critical barriers for VR adoption in training, providing the knowledge, tools and strategies to design, implement, and effectively employ VR technology effectively in the classroom.